Molecular Mechanism of Mechanosensation

DESCRIPTION (provided by applicant): Mechanosensation provides two of the 5 fundamental senses integral to human sensation-touch and hearing. Surprisingly, the seemingly simple sense of touch lacks a satisfactory molecular description in eukaryotes. The question remains: How do molecules in a cell sense and transduce mechanical force in tissue? In mammals ion channels are believed to play a role in mechanosensation; however, studies of mechanosensitive channels have failed to identify a clear structural domain or feature responsible for sensing mechanical force. Absent a clear mechanism for mechanosensation in humans, testable hypotheses are needed to arrive at a correct model. This proposal presents an argument that lipid interactions with ion channels are important to mechano sensation. Forming a molecular description of force transduction will, one, complete our understanding of sensory perception and, two, reveal targets for therapeutic intervention in pain and hearing loss.

Public health relevance
This proposal provides a unifying theory for how humans sense touch. Lipid membranes are key perceiving touch and its close cousin pain. Novel lipid based therapies are proposed for badly needed non-addictive therapies in treating chronic pain.